NCI Diversity Supplement: Glioma therapy with oncolytic adenoviruses and immunometabolic adjuvants

ABSTRACT
A separate Abstract is not requested.
This is an NCI Diversity Supplement to Dr. Juan Fueyo-Margareto’s NCI grant, R01 CA256006,
titled, “Glioma therapy with oncolytic adenoviruses and immunometabolic adjuvants.”

Public health relevance
PROJECT NARRATIVE Project Narrative is not required for NCI Diversity Supplement. This is an NCI Diversity Supplement to Dr. Juan Fueyo-Margareto’s NCI grant, R01 CA256006, titled, “Glioma therapy with oncolytic adenoviruses and immunometabolic adjuvants.”